BIOCHEMICAL MECHANISMS OF MAST CELL DEGRANULATION--STUDIES WITH DISRUPTED CELLS

Prolonged exposure of rat basophilic leukemia (RBL-2H3) cells to dexamethasone resulted in global suppression of various stimulatory events in response to antigen and a global enhancement of the same stimulatory events to the adenosine analog, N-(ethylcarboxamide)adenosine (NECA). We had previously shown that antigen and NECA both activate phospholipase C but by different mechanisms; cells that had been treated with cholera or pertussis toxin, for example, responded to antigen but not to NECA with the release of inositol phosphates, increase in levels of cytosolic Ca2+, and secretion. Because the toxins still inhibited the responses to NECA in dexamethasone-treated cells, the effects of dexamethasone may have been exerted at the level of receptor/G-protein coupling rather than at the level of effector systems. Additional evidence for this was the following: 1) NECA-induced hydrolysis of the inositol phospholipids was still enhanced after permeabilizing and washing the cells; 2) the response to the G-protein stimulant GTP(tau)S was also enhanced in permeabilized, dexamethasone-treated cells and 3) kinetic studies suggested that the enhanced responsiveness to NECA was attributable in part to an increase in receptor number. The suppressive action of dexamethasone on antigen induced hydrolysis of inositol phospholipids, however, was readily lost by permeabilizing RBL-2H3 cells. The results indicate, therefore, that treatment with dexamethasone leads to changes in receptor-coupling mechanisms that are either resistant to (i.e., NECA-mediated responses) or reversed by (i.e. antigen-medicated responses) cell permeabilization.